Delivery of a candidate AgTRIOVx malaria vaccine by thermostable microneedle patches

ABSTRACT
Malaria remains one of the deadliest infectious diseases. Although much progress has been made
in the fight against malaria, a highly effective and durable vaccine is not available. New vaccine
candidates and improved delivery strategies are urgently needed. We recently demonstrated that
a Anopheles gambiae mosquito saliva protein, called AgTRIO, is a viable mRNA-LNP vaccine in
mice, either as a single agent or in synergistic combination with the target of the currently
marketed RTS,S/AS01 vaccine (Mosquirix). This project addresses the real-world problem of
delivery of an antimalaria mRNA vaccine in endemic, resource-poor countries where cold-
chain storage hugely limits deployment of mRNA vaccines. Our product solution employs
novel dissolvable microneedle patches (MNPs) to administer our AgTRIO mRNA-LNP
formulation. These microneedle patches can be self-applied, are less painful than intramuscular
injection, produce no sharps waste, have a long-term shelf life for up to six months at room
temperature, and can be produced at scale with robust methods. The single specific aim of this
project is to produce a novel AgTRIOVx MNP that protects against malaria in a mouse model in
preparation for pre-clinical and human clinical studies at a future phase.

Public health relevance
NARRATIVE The continued devastating consequences of malaria underscore the urgent need for novel preventive strategies against the disease. The proposed project will deliver an antimalaria mRNA vaccine using dissolvable microneedle patches (MNPs), addressing the issues of cold- chain storage and hypodermic needle delivery, which are hugely limiting factors in vaccination, particularly for populations residing in endemic, resource-poor countries.